University of Washington Developmental AIDS Research Center for Mental Health (UW ARCH)

OVERALL ABSTRACT
The proposed University of Washington (UW) Developmental AIDS Research Center (D-ARC) responds to the
global HIV epidemic at a critical stage. Though more than 21 million people around the world receive antiretroviral
therapy, the most marginalized populations continue to experience high incidence, less access to effective
prevention and care, and greater mortality. Unmet needs persist in high-prevalence countries as well as
“geographic hotspots” in the US such as Seattle's King County. Intersecting stigma, trauma, poverty, and
substance abuse increase risk for mental illnesses, yet the effective treatments available are rarely implemented.
The proposed D-ARC aims to address these challenges by catalyzing research that helps end the
epidemic, with a focus on integrating care for mental disorders into HIV prevention and treatment
strategies. Furthermore, Center investigators will support and apply the science of dissemination and
implementation, with the overall goal of bringing such interventions to scale. The D-ARC aims to fill a gap
in HIV behavioral science research at UW by capitalizing on the considerable strengths of UW's HIV expertise
and bridging this with UW's longstanding leadership in the development and delivery of models of integrated
mental health care. By combining UW expertise in (a) HIV research and (b) mental health care—now siloed
geographically, programmatically, and conceptually—the Center will be a synergistic force capable of realizing
is mission of Implementing Innovative Impactful Integrated Interventions. The proposed infrastructure capitalizes
on the strengths of local expertise and broad ties with global collaborative networks, adding value to UW through
the Center's administration, research support, and training missions, buttressed through additional institutional
commitments of $762,296. Cross-cutting themes of the D-ARC are (a) leveraging local and global bidirectional
pathways to learning and innovation by engaging communities of providers and (b) addressing inequities by
testing research solutions that reduce disparities. Four proposed Cores address the Overall specific aims: 1)
Catalyze and support innovative and impactful research to curb the HIV epidemic, with a focus on integrated
intervention strategies (Administrative Core); 2) Provide needed technical assistance and training on research
design, measurement, theory and novel statistical methods relevant to mental health and HIV research (Methods
Core); 3) Stimulate practice-based research that promotes effective integrated mental health services in HIV
care settings and disseminate findings broadly (Integrated Care Core); and 4) Nurture the Next Generation of
diverse, multidisciplinary HIV researchers through training and innovative mentorship of early stage investigators
and mentors (Developmental Core).

Public health relevance
PROJECT NARRATIVE The University of Washington Developmental AIDS Research Center for Mental Health, based in Seattle, catalyzes new mental health and HIV research and develops new research leaders across the multidisciplinary spectrum of clinical, epidemiologic, statistical, behavioral, and implementation science expertise necessary to bend the curve of the global HIV epidemic. Our team blends expertise in HIV prevention, care and treatment, management of complex patients with HIV and co-morbidities, models of mental health care delivery in primary care, user-centered design for effective deployment of evidence-based psychological interventions in diverse care settings, care for co-morbid traumatic stress and substance use disorders, management of co-occurring mental disorders and other medical conditions, and rigorous quantitative methods for social science research. We bring experience in the conduct of impactful research with partners in regional and global HIV care settings and through the work of our four Cores we aim to catalyze and support innovative and impactful research to curb the HIV epidemic, with a focus on integrated intervention strategies that address HIV and mental disorders.